Uncovering roles of polyunsaturated fatty acids in pancreatic cancer etiology

Basic research suggests that different polyunsaturated fatty acids (PUFA) (n-6 and n-3) may play differentiated roles in pancreatic cancer development. However, findings from human studies, which are conducted primarily among Caucasians, have been limited and inconsistent. Conventional studies suffer from several methodological limitations. The proposed project will apply a series of new studies to address the gap of understanding the role of PUFA in pancreatic cancer etiology. The exposure patterns of PUFA (amounts and/or ratio) differ across ethnicities, with African Americans (AAs) in the high end and Asians in the low end. In the K99 phase, Dr. Wu will evaluate the association between PUFA dietary intake and pancreatic cancer risk in Asians, AAs, Whites, Latinos, and Native Hawaiians using data from four prospective cohort studies (the Shanghai Women's Health Study (SWHS), the Shanghai Men's Health Study (SMHS), the Southern Community Cohort Study (SCCS), and the Multiethnic Cohort Study (MEC)). Using data from the Pancreatic Cancer Cohort Consortium (PanScan) and Pancreatic Cancer Case-Control Consortium (PanC4), Dr. Wu will also investigate the association between genetically-determined PUFA levels and pancreatic cancer risk primarily in Caucasians using a Mendelian randomization design with instrumental variable of genetic scores composed of fatty acids blood level associated variants. In the R00 phase, Dr. Wu will lead research to assess whether PUFA levels in pre-diagnosis red blood cells are associated with pancreatic cancer risk in the five ethnic groups using a nested case-control study design of the SWHS, SMHS, SCCS and MEC. These studies with complementary strengths will lead a better understanding of the role of PUFA in pancreatic cancer etiology. Furthermore, Dr. Wu will investigate whether the association of dietary intake of PUFA with PC risk is modified by genetic background of PUFA metabolizing genes and GWAS-identified PC susceptibility variants using resources from PanScan and PanC4. This will provide an in depth understanding of the interaction between PUFA dietary intake and genetic background in absorbing and metabolizing PUFA as well as host susceptibility on development of pancreatic cancer. The knowledge gained would eventually lead to a development of individualized pancreatic cancer prevention program. During this K99/R00 award Dr. Wu will gain additional skills and experience in nutritional and molecular epidemiology, which will propel him into a career as an independent investigator and leader in the field of cancer epidemiology. The findings from this research project will be used to develop and submit R01 level projects before the completion of the Career Development Award.

Public health relevance
Narrative Pancreatic cancer is the fourth leading cause of cancer mortality in the United States. Although polyunsaturated fatty acids are suggested to potentially influence pancreatic cancer risk through modulating inflammatory activities, the exact relationship remains unclear. This study will apply a multidisciplinary approach to comprehensively evaluate the role of polyunsaturated fatty acids in pancreatic cancer etiology and may generate important new knowledge for developing individualized pancreatic cancer prevention strategies.